Chronic Antibiotic Suppression after Prosthetic Joint Infection: A Target for De-implementation

Background: The VA has pledged to reduce overuse of antibiotics, and is a partner in the National Action
Plan to combat antibiotic-resistant bacteria. Overuse of antibiotics can lead to Clostridium difficile infections
among the individuals receiving antibiotics, as well as antibiotic resistance that can complicate treatment of
future infections for all patients. Chronic antibiotic suppression (CAS) is defined as indefinite use of oral
antibiotics following initial guideline recommended intravenous and oral antibiotics. There is evidence that CAS
may be inappropriately used and overused. Thus, there is a critical need to examine how CAS is prescribed,
and who benefits the most, and who is harmed, from CAS therapy. This knowledge can be used to develop an
intervention to de-implement and optimize CAS use. In this study, we will examine CAS treatment for
prosthetic joint infections (PJIs). PJIs occur after hip, knee or shoulder replacement surgery and are associated
with a high clinical and economic impact. In the VHA system, over 10,000 hip, knee or shoulder replacement
surgeries are performed each year and this number, as well as the number of associated PJIs, continues to
increase. Treatment for PJI after hip, knee or shoulder replacement surgery is important to the VA because
osteoarthritis, the most common reason for that surgery, is the fifth most common condition among Veterans.
Our pilot data and other studies have found that many PJI patients are prescribed CAS outside of guideline
recommendations, potentially due to physician fear of a relapse. This inappropriate use can lead to poor
patient outcomes (e.g., C. difficile infection, antibiotic resistance) without any benefit.
Research Plan: The specific aims of this study are: (1) Define patient, infection, and treatment characteristics
that identify patients who would benefit from de-implementation of CAS; (2) Define current provider CAS
prescribing processes and evaluate barriers and facilitators to changing those practices through interviews with
health care providers; and (3) Create a decision model to conduct an economic evaluation of CAS use and
different interventions to de-implement inappropriate CAS use. We expect to document significant variations in
CAS prescribing and identify cost-effective interventions to de-implement CAS or reduce its duration.
We propose a 3-year mixed methods study to inform efforts for CAS de-implementation. Aim 1 will use a
Corporate Data Warehouse (CDW) database of ~7,500 PJI patients treated at all VA hospitals in a
retrospective cohort comparative effectiveness study to determine specific characteristics that identify those
PJI patients who will benefit from CAS de-implementation. These characteristics may include young age,
infection with a non-virulent pathogen, initial receipt of appropriate antibiotics for PJI caused by
Staphylococcus aureus, or receipt of 2-stage exchange surgery. In Aim 2, we will visit 8 diverse hospitals,
qualitatively explore the contexts that contribute to CAS use, and elicit barriers and facilitators to changing
prescribing practices. Aim 3 will create an innovative decision analytical model of potential interventions to de-
implement CAS or reduce its duration. Our findings will be provided to the VA Antimicrobial Stewardship Task
Force to assist in antibiotic de-implementation efforts and will provide needed data to design a future
randomized controlled trial of an intervention to de-implement CAS among patients who do not need it.
Implications: Our study will provide important insights into the organizational culture and broader external
context (e.g., professional, social) associated with over-prescribing antibiotics for infections after surgery. We
will identify targets for antimicrobial stewardship and identify clinical situations in which antibiotic use can be
de-implemented. Given the increasing use of implants such as prosthetic joints, cardiac pacemakers, and left
ventricular assist devices, the use of CAS is expected to rise. Our research will help VA providers de-
implement antibiotics for patients who do not need them, in order to decrease antibiotic resistance in the VHA
and prevent adverse events such as C. difficile infections.

Public health relevance
Prosthetic joint infection (PJI) is an infection that occurs after hip, knee or shoulder replacement surgery. Chronic antibiotic suppression (CAS), defined as indefinite use of oral antibiotics (lasting between 6 months to 10 years) following an initial course of antibiotics, is frequently used to treat PJIs. However, overuse of CAS among low-risk patients who do not need it can result in antibiotic resistance and life-threatening adverse events. The overall goal of the proposed study is to create a cost-effective intervention to decrease overuse of CAS. First, we will use VA data to determine patients who do not benefit from CAS and may be harmed by CAS-associated adverse events. Second, we will interview doctors and nurses at 8 hospitals to determine how and why CAS is prescribed and how to change practice if needed. Third, we will use mathematical modeling to determine the most effective and cost-effective intervention to reduce overuse of CAS.